Does the Maternal Environment During Viral Infection and Inflammation Direct Fetal Gamma Delta T Cell Development and Function?

Existing evidence emphasizes the importance of the role played by the maternal environment, particularly the
intrauterine environment, in fetal and early development and in the trajectory of adult life. The understanding of
the underlying molecular pathways and related biologic correlates is thus of critical importance to several
institutes of the NIH. This application is in response to PAR-20-298, which highlights the importance of
understanding the role of the maternal environment in the development of the immune system. To fully and
innovatively examine this issue we think requires examination of cells at the interface between innate and
adaptive immunity. A key component of this interface are γδT cells (GDT). These cells can be intimately located
within tissues at the maternal-fetal interface, where they may be supportive of both pro and anti-inflammatory
responses and may mediate adverse pregnancy or neonatal outcomes.
Recent evidence suggests that these cells may play an important role in neonatal immunity. We have used a
mouse model to study the development of GDT. These cells develop early in the thymus, beginning around day
14 of gestation. Day 17 of gestation is a critical timepoint for generation of specific functional subsets, e.g.,
expression of IL-17, of GDT. Therefore, GDT development is likely influenced by the maternal environment.
Further, evidence suggests that GDT mediate anti-cancer and autoimmune responses in addition to protective
immunity depending on their functional subset. Thus, in utero programming of GDT has long term consequences
for the life of the offspring. We thus have the overall hypothesis, that maternal infectious and inflammatory
responses are critical mediators of the immunologic milieu which regulates GDT development and function. To
probe this hypothesis, we seek to utilize a mouse model of viral infection with Lymphocytic Choriomeningitis
virus (LCMV). We have shown that acute maternal infection at mid gestation results in a persistent
placental/decidual infection which is modified by local CD8 T cells. However, the response and regulation of
local GDT is not known. Further, though the fetus appears to remain protected against productive infection,
outcome of neonatal immunity in this situation has not been fully explored. Our group of experts in GDT cell
development and maternal and fetal immunity seeks to use LCMV infection and to utilize the tools of
multiparameter flow cytometry and single cell RNA seq to: i) determine the outcome of viral infection or
inflammation on uterine and placental GDT presence and functional capacity, ii) determine the phenotype and
function of neonatal GDT in response to maternal viral infection and iii) relate maternal infection, early GDT
development and subsequent GDT-related response in mouse models of autoimmunity and cancer. These
studies will contribute to growing data on the important influence of the maternal environmen on long term health.
They will eventually impact our management of viral susceptibility and infection during pregnancy, vaccination
of pregnant women, and the diagnosis and treatment of infants born to infected mothers.

Public health relevance
Education of the immune system begins in utero. We will use a mouse model to understand how maternal acute or chronic viral infection and inflammation during pregnancy guide the development γδ T cells. These cells are important to immune responses at sites in contact with the outside world, especially, skin, lung, gut and vagina.